MUSC SCORE Biostatistics Resource Core

ABSTRACT
The Biostatistics Core Resource provides comprehensive biostatistics analysis and data management support
to the entire SCORE team. The Core’s primary goals are to ensure (1) research conducted in the SCORE is
based on efficient experimental design, (2) quantitative methods used in the SCORE research are appropriate
for the design of the study and for the data generated and assumptions required for these methods are
appropriate and (3) data collected in the Projects are managed and subjected to rigorous quality control to minimize
the possibility of errors and are organized in a manner that facilitates inter-project collaboration. The Biostatistics
Resource Core will also work closely with the SCORE Leadership Administrative Core to provide statistical
support for the Pilot Project Program, and the SCORE Career Enhancement Core to provide statistical training
and assistance for SCORE Scholars. Biostatistics Resource Core members have a long history of collaboration
with the investigators on this SCORE. Biostatistics analysis and data management support will be centralized
within the Core to ensure necessary expertise is always available to all members of the SCORE and to facilitate
multiple utilization of the same expertise as well as contribute to the dissemination of state-of-the art analysis
techniques. Moreover, the Core is well poised to initiate and promote interactions among SCORE projects and
investigators as well as support cross-SCORE and other extra-center collaborations.

Public health relevance
PROJECT NARRATIVE The Biostatistics Resource Core provides centralized support to the entire MUSC SCORE team of investigators and strives to promote synergy in terms of study design and analyses across projects and other shared resources. It also contributes to the career enhancement and dissemination missions of the MUSC SCORE.